Administrative Core

Project Summary/Abstract – Administrative Core
This innovative integrated systems biology application seeks to further delineate the complex host/pathogen
interactions occurring at the alveolar level that lead to unsuccessful response to therapy in serious pneumonia.
The SCRIPT2 Systems Biology Center is intentionally multidisciplinary, increasing the complexity of interactions
and mandating a centralized approach to facilitate accomplishing the goals of this Systems Biology Center. The
major premise of the SCRIPT2 Systems Biology Center research agenda is an iterative approach to
host/pathogen interactions based on results of high throughput omics approaches and mathematical modeling
of the results. We therefore expect that prior results will drive subsequent experiments. Integration and facilitation
of these subsequent experiments between the different Cores and investigators will be the primary responsibility
of the Administrative Core. The Administrative Core will also ensure that data generated by the Projects and Cores
are disseminated in formats that are useful to the larger community of pneumonia and infectious diseases
researchers. The Administrative Core will accomplish these objectives in four specific aims:
Aim 1. To support communication between Project Investigators, Core Leaders, other U19 Systems
Biology Center Investigators, and NIAID Program Staff. The Administrative Core will be responsible for
coordinating communication across the entire range of Center activities, including internal relationships with the
multidisciplinary SCRIPT2 investigators, with other U19 Centers, and with NIH/NIAID program staff.
Aim 2. To provide a structure for the distribution of common resources and the dissemination of
information, as well as regulatory oversight and budgetary and personnel resource management, to the
Project Investigators and Core Leaders. We expect that prior modeling results will drive subsequent analyses
or data/sample collection. Integration and facilitation of these subsequent analyses between the different Cores
and investigators will be the primary responsibility of the Administrative Core.
Aim 3. To disseminate the discoveries made by Project Investigators through publications,
presentations, and the sharing of materials and raw data to other institutions and investigators, including
via NIAID-directed public databases/repositories. We are committed to making our data Findable,
Accessible, Interoperable, and Reusable (FAIR).
Aim 4. To foster a local and external environment of collaborative interdisciplinary research and
mentoring of trainees to promote a systems biology approach to pneumonia, other infectious diseases,
and other critical illnesses. We believe that the SCRIPT2 Systems Biology multi-omics and mathematical
modeling approach to severe pneumonia is pertinent to other infections and other critical illnesses. The Admin
Core will organize a suite of local and outreach activities to foster this approach.